Riboflavin biosynthesis and utilization in Mycobacterium tuberculosis

SUMMARY
The search for more effective treatment and prevention of tuberculosis has motivated the identification
genes that are essential for the growth and survival of the causative agent, Mycobacterium tuberculosis (Mtb).
These genes are potential new targets for developing and attenuated live vaccines. For example, targeting
metabolite biosynthesis can prevent Mtb from making essential building blocks and generate auxotrophs that
induce protective immunity, but do not cause disease. Riboflavin (vitamin B2) biosynthesis has been proposed
as a drug target because putative biosynthetic genes have been shown as essential in multiple transposon
screens, but Mtb is assumed to be unattainable as a riboflavin auxotroph and depend entirely on de novo
synthesis in vivo because it lacks a homologue for a known bacterial riboflavin transporter. However, our
critical review of the literature along with our preliminary data on inducible knockdown strains for riboflavin
biosynthesis genes provide an opportunity to test our central hypothesis that Mtb takes up riboflavin via a
noncanonical transport mechanism. We will test this hypothesis by identifying metabolites and genes that
support Mtb growth when riboflavin biosynthesis is disrupted and determining whether riboflavin metabolites
are limiting for Mtb growth in the host. If our hypotheses are correct, we expect to identify novel aspects of Mtb
metabolite uptake and utilization and determine the feasibility of target riboflavin biosynthesis as drug targets in
vivo, with potential impcats for the study of metabolite transporters in other intracellular pathogens.

Public health relevance
Project Narrative The research is this proposal is relevant to public health because understanding pathways essential for the growth and survival of mycobacteria is a necessary first step in developing new therapeutics for and combatting antibiotic resistance in mycobacterial diseases, including tuberculosis. Thus, the proposed work is relevant to the NIAID mission, which includes supporting basic research toward improved understanding, treatment, and prevention of infectious diseases.